National Forum for Heart Disease & Stroke Prevention Annual Meeting 2024 - Advancing Health Equity Throughout America: Novel Data-Driven Approaches

ABSTRACT
The National Forum for Heart Disease & Stroke Prevention (National Forum) seeks funding in support of its
2024 Annual Meeting with the theme of “Advancing Health Equity Throughout America: Novel Data-Driven
Approaches”. The meeting will raise awareness and fluency in the newly developed Vital Conditions for
Health and Wellbeing (Vital Conditions) framework among medical and public health practitioners and
researchers. It will also ensure that discussions on health equity and its implications for cardiovascular disease
are framed within the Vital Conditions principles and recommendations. Furthermore, it will also present the
importance of using data-driven approaches to achieve improvements in health policy and healthcare systems
as well as increase perception of health equity and actions at community and individual levels. The meeting
specific aims/goals are (1)To engage public health professionals, health care decision-makers, researchers,
and the public in a conversation about the health equity implications of the Vital Conditions of Health and
Wellbeing, and how they can become the new norm within public health and healthcare settings. (2) To
identify data-driven approaches that can best inform the Vital Conditions levers for community change and
improvement. (3) To track, compile and disseminate improvements that meeting participants have taken back
to their constituents to form a practical body of knowledge on how the Vital Conditions can improve health
outcomes. The National Forum’s impact in previous meetings has been to bring together stakeholders who
then take diverse perspectives and action items back to their constituents to enact practical changes to
enhance health outcomes and community resilience as relates to cardiovascular health. In line with previous
convenings, we expect 300 participants at our Annual Meeting 2024 from across all health sectors with
significant underrepresented minority and women participation as reflected in our organizing committee and
speaker panel. Follow up activities will include on-demand video, a summary of recommendations and a digital
one pager with links to all conference materials and references. It will also include tracking of ideas, actions, or
policies that were implemented because of the strategies and information presented at the meeting to create a
national map of impact.

Public health relevance
PROJECT NARRATIVE The National Forum for Heart Disease & Stroke Prevention (National Forum) 2024 Annual Meeting has the theme of “Advancing Health Equity Throughout America: Novel Data-Driven Approaches”. The meeting will raise awareness and fluency in the newly developed Vital Conditions for Health and Wellbeing framework among the anticipated 300 attendees including diverse medical and public health practitioners and researchers. It will also ensure that discussions on health equity and its implications for cardiovascular disease are framed within the Vital Conditions principles and present the importance of using data-driven approaches to achieve improvements in health policy and healthcare systems.